A new approach to monitoring glycosylation during glycoprotein production

PROJECT SUMMARY
During the production of therapeutic biologicals, glycosylation has been identified as a critical quality attribute
(CQA) that must be carefully monitored to ensure that the desired protein stability, immunogenicity, antibody
effector function, pharmacological safety and potency, and serum half-life are consistently obtained. Many
factors can affect the composition of the glycan chains during production, such as media, temperature,
dissolved gases, induction times, etc., and consequently variations in glycosylation are among the leading
causes of pharmaceutical batch rejection.
Currently, the characterization of protein glycosylation relies heavily on methods that employ chromatography
and/or mass spectrometry, which require a high level of expertise, are time-consuming and costly, and,
because they are challenging to implement during biologics production at-line, are generally performed only
post-production. In recognition of the continuing need for novel analytical technologies that can be used during
therapeutic production, the US Food and Drug Administration (FDA) encourages the adoption of new process
analytical methods (PAT) that offer mechanisms to design, analyze, or facilitate the measurement of process
parameters that affect CQAs. Here we propose to optimize and commercialize a simplified approach for
monitoring glycosylation features during glycoprotein production, which we call GlycoSenseTM, that is fully
aligned with the FDA PAT initiative.
The GlycoSense technology uses flow cytometry with glycan-specific reagents conjugated to multiplex beads
to provide a rapid, inexpensive, and easy-to-use method for monitoring protein glycosylation patterns. Flow
cytometry was chosen as the preferred platform because the data are statistically robust, the equipment is
relatively commonplace, the analyses consume very low quantities of sample, and it will enable Lectenz Bio to
leverage its proprietary expertise in producing carbohydrate-sensing reagents.
In preliminary studies reported here, GlycoSense performance metrics were established and published using
glycans and glycoprotein standards. In phase II, the technology will be optimized for monitoring glycosylation
changes during cell culture. This will result in GlycoSense kits that can be used for a variety of applications in
basic research and in biopharma.

Public health relevance
PROJECT NARRATIVE Therapeutic glycoproteins (biologics) such as antibodies address critical health care needs, but there are currently no simple methods for analyzing the attached glycans (sugar molecules) during the biologics production. The ability to monitor the glycosylation of biologics during their production would be transformative for biopharmaceutical R&D and would accelerate the creation of new biologics and biosimilars. Our innovative technology enables monitoring of protein glycosylation in near real-time in a robust and convenient manner.